Targeting PLK1 signaling for the treatment of fibrolamellar carcinoma

PROJECT SUMMARY
Fibrolamellar carcinoma (FLC) is a childhood liver cancer with a high case mortality rate. Patients with FLC
typically present with advanced disease, as there are no early warning signs. Thus, a cure by surgical resection
is rarely attainable. In addition, FLCs are notoriously resistant to chemotherapies and other targeted therapies
currently approved for liver cancer, leading to a 5-year survival of just 30%. New therapeutic strategies that
counteract the molecular signaling events that go awry in FLC are urgently needed. FLC is characterized by a
fusion event resulting in a novel chimeric protein that joins the N-terminal domain of DNAJ with the catalytic
subunit of protein kinase A (PKAc) in hepatocytes. However, the underlying mechanism by which DNAJ-PKAc
drives FLC tumor growth remains unknown.
This project's overall goal is to apply an unbiased systems-based
approach to identify and validate druggable signaling networks that regulate the growth of DNAJ-PKAc-
expressing FLC cells and uncover a mechanistic understanding of how DNAJ-PKAc chimeric protein drives FLC.
The paucity of preclinical models such as immortalized primary human FLC cell lines has precluded many
investigators. Our lab has established three new model systems to address this significant gap: patient-derived
cell lines bearing the FLC gene fusion, organotypic cultures, and patient-derived xenograft (PDX) mice. Utilizing
these model systems, we carried out a systems-pharmacology-based functional kinase inhibitor screening in
FLC cells and normal hepatocytes. We identified and confirmed the role of PLK1 kinases as essential for the
growth of FLC cells. Genetic depletion or pharmacological inhibition of PLK1 selectively reduces the growth of
multiple patient-derived FLC cell lines and the viability of FLC organotypic tissue slices. Further, treatment of the
FLC tumor with PLK1 inhibitor significantly reduced the tumor growth in the PDX model. PLK kinases are key
regulators of centrosome maturation and mitosis. Follow-up experiments suggest that DNAJ-PKAc chimera
localizes to the centrosomes where it physically interacts with PLK1.Thus, we hypothesize that the heightened
sensitivity of the FLC cells to PLK inhibition stems from the localization of the DNAJ-PKAc fusion protein to the
centrosome, its association with the PLK1 complex, thereby enhancing the activation of PLK1 and promoting
mitotic progression. We propose to 1. uncover molecular mechanisms of how DNAJ-PKAc fusion alters PLK1
activation and function, and 2. evaluate the efficacy of clinical-grade PLK1 inhibitors alone and in combination
with chemotherapy in preclinical models.Functional analyses will highlight the mechanistic insights by which
DNAJ-PKAc drives FLC tumor progression and the role of the PLK1 signaling complex in FLC survival, thus
deepening our understanding of disease pathogenesis. Our cross-disciplinary team consisting of Drs. Gujral,
Scott, and Yeung represent a cohesive collaboration that brings systems biology, PKA biochemistry, and state-
of-art human-derived FLC cancer models to address this deadly disease. Our findings have translational
significance as they will provide a rationale for targeting critical signaling nodes that sustain FLC tumors' survival.

Public health relevance
PROJECT NARRATIVE Fibrolamellar carcinoma, a life-threatening variant of liver cancer affecting adolescents and young adults, is characterized by a fusion event resulting in a novel chimeric protein that joins the N-terminal domain of DNAJ with the catalytic subunit of protein kinase A (PKAc). We aim to identify and validate druggable signaling networks that regulate the growth of DNAJ-PKAc fusion-expressing FLC cells. The knowledge gained from this study will accelerate the development of a novel therapeutic option for targeting childhood liver cancer.